Postgraduate Training in Epithelial Biology

This competing renewal of the Postgraduate Training Program in Epithelial Biology, AR07422, aims to
extend 40 continuous years of NIH-supported postdoctoral training in skin research at Stanford. The
program objective is to train postdoctoral fellows for future careers in research relevant to skin diseases.
The rationale for the multi-disciplinary design of the program within the Stanford Program in Epithelial
Biology is based on the premise that future success in cutaneous biology research will be enhanced by
training interactions within a broad scientific network.
Developments during the prior funding cycle include:
1) Expansion of the Stanford Program in Epithelial Biology (PEB): AR07422 is the heart of the multi-
disciplinary PEB, which has grown to 74 Stanford faculty united by themes common to skin and other
epithelial tissues, including differentiation, morphogenesis, adhesion, stem cell biology, carcinogenesis,
and therapeutics, which together comprise T32 training foci. The current proposal has also expanded to
include training opportunities in translational and population sciences research, directed by world leaders in
those fields.
2) Enrichment of the T32 training environment: Embedded among basic science faculty, the core
Dermatology labs leading this T32 have been further enriched by 24 Ph.D. students pursuing thesis efforts,
a 25% expansion in research space in 2016, new equipment, new high throughput genomics core facilities,
and a new in-lab core biocomputational training resource.
3) Enhancement of multi-disciplinary resources available to trainees: In addition to the PEB, T32 mentors
expanded their involvement and leadership in additional multi-disciplinary programs at Stanford, spanning
Stanford Stem Cell Biology, Cancer Biology, Biomedical Data Sciences, and Genomics Programs.
4) Acceleration of the scientific productivity of the Stanford skin research training community:
Productivity, measured by high impact papers (journal ISI impact factor >25) has accelerated, with 21 such
publications from the core Dermatology mentors over the prior funding cycle.
5) Successful training of future PIs: 11 Research P.I.s graduated from the laboratories of the 4
Dermatology core mentors over the current funding cycle and are now Assistant Professors at institutions
that include Baylor College of Medicine (1); Icahn School of Medicine at Mount Sinai (1); University of
Southern California (USC)(1); Yale School of Medicine(1); University of California San Francisco (UCSF)
(1); Lausanne University Hospital, Switzerland (CHUV) (1), Shanghai Jiao Tong University School of
Medicine (1); Shenzhen Institute of Advanced Technology, China(1); Sun Yat-Sen University, China (1);
Ulsan National Institute of Science and Technology, South Korea (1); Uppsala University, Sweden(1).

Public health relevance
PROJECT NARRATIVE Effective training of scientists capable of successfully conducting independent research is critical for continued progress in biomedical research directed at meeting future public health needs. The Postgraduate Training Program in Epithelial Biology is designed to train new scientists in disciplines relevant to the understanding, prevention and treatment of skin disease.